Functional exploration of a deep Mycobacterium tuberculosis phosphoproteome

ABSTRACT
Phosphosignaling provides the major conduit for bacterial adaptation. The two component systems (TCSs)
have long been viewed as the canonical phosphosignaling systems in bacteria, but increasingly, O-
phosphorylation mediated by Ser/Thr kinases is recognized as a relevant bacterial phosphosignaling
mechanism as well. We now show that in fact, Mycobacterium tuberculosis (Mtb) has an expansive,
distributed, and cooperative O-phosphorylation system of a size and complexity that is typically only associated
with eukaryotes. By using a comprehensive STPK loss- and gain-of-function mutant panel and quantitative
mass spectrometry, we show that >70% of Mtb proteins are phosphorylated on Ser/Thr/Tyr, identify thousands
of individual Ser/Thr kinase substrates, and show that the Ser/Thr kinases collectively control the expression of
~30% of Mtb genes. Here, we will test a new and extensive regulatory connection between the Ser/Thr kinases
and the His kinases of the TCSs and test the role of O-phosphorylation on the regulation of transcription
factors. As a result of our exhaustive analysis of Mtb phosphorylation, we also obtained the first evidence of
Arg phosphorylation in Mtb- the first bacterial Arg phosphoproteome outside of gram-positive bacteria. We will
identify the relevant phosphoenzymes and test the idea that pArg functions as a degradation tag for ClpP-
mediated proteolysis.

Public health relevance
NARRATIVE Phosphosignaling is the primary means by which bacteria sense their environment and is thus critical for bacterial pathogenesis. This study will identify new phosphosignaling pathways in Mycobacterium tuberculosis, the causative agent of tuberculosis.